UNC-CH NADIA Scientific Core

DESCRIPTION (provided by applicant): The primary objective of this NADIA core is to integrate and expand the Consortium research projects. The hypothesis of the Scientific Core is that adolescent intermittent ethanol (AIE) impacts brain development and induces specific neuro-adaptations that persist into adulthood as a specific neurochemical and morphological phenotype. Thus, the Scientific Core will serve and link NADIA components by providing neurochemical and morphological brain atlases that will define the phenotype of the brain exposed to alcohol during adolescence. Each component will send brains to the core for immunohistochemical determination of pivotal neurotransmitter gene expression in brain regions related to the physiology and behaviors being studied. Additionally, Magnetic Resonance Imaging (MRI) and Diffusion Tensor Imaging (DTI) data will be collected on select data sets in order to provide global structural information on the impact of different AIE models on adult brain. Finally, all the resulting data will be shared and unused brain tissue will be archived to allow for future analysis. Together, these approaches will provide critical information on neurobiological mechanisms that underlie AlE-induced changes in adult behavior and physiology. The Scientific Core will use an animal model of adolescence alcohol drinking to investigate how alcohol changes brain structure and neurochemistry. This endeavor, along with the resulting data repository, serves to integrate the research components of the NADIA Consortium and will provide a foundation for understanding differences in adolescent life trajectories and maturation of important behavioral repertoires. PUBLIC HEALTH RELEVANCE: The Scientific Core will use an animal model of adolescence alcohol drinking to investigate how alcohol changes brain structure and neurochemistry. This endeavor, along with the resulting data repository, serves to integrate the research components of the NADIA Consortium and will provide a foundation for understanding differences in adolescent life trajectories and maturation of important behavioral repertoires.